EPIDEMIOLOGY OF DIABETES INTERVENTION &COMPLICATIONS

We will follow 60 individuals who were enrolled in the Diabetes Control and Complications Trial. These patients will be followed for up to 10 additional years. We wish to determine if a period of intensive glycemic control will prevent or forestall vascular complications, retinopathy, and neuropathy.